Administrative Core

Summary Administrative Core
The Administrative Core (AC) of the Caribbean Cancer Research Center on Environmental and Natural Hazards (CARIB-CARES) will provide infrastructure for the collaboration between the primary institutions (the University of Puerto Rico Comprehensive Cancer Center, the University of Puerto Rico-Medical Sciences Campus, and the University of the Virgin Islands-Caribbean Exploratory Research Center) and ancillary sites (the University of Miami, the American Cancer Society, the University of South Florida and the University of Arizona) to ensure the success of the proposed Center. The AC will support and oversee all the components of CARIB-CARES, including implementing the proposed research project, the Community Engagement Core, and training and capacity building in Puerto Rico (PR) and the US Virgin Islands (USVI). Increasing infrastructure, capacity, and research related to the impact of extreme weather events and pollution on the cancer control continuum will foster the development of investigators with expertise in this area in the Caribbean and will help guide risk reduction and mitigation efforts. The AC’s specific aims are: 1) Lead, oversee, and coordinate effective and sustainable integration and communication between the Principal Investigators, the Projects, and the Cores of the CARIB-CARES; 2) Provide the necessary infrastructure, administrative, and operational support to carry out the Projects and Cores within the CARIB-CARES; 3) Support the career development of students and researchers from the Caribbean region focusing on the impact of natural and environmental hazards on the cancer control continuum; 4) Support the development and implementation of outreach and community-based activities (Community Engagement Core) within the CARIB-CARES, as well as collaborations across PR and the USVI to support the sustainability of these efforts; 5) Monitor and evaluate the implementation and execution of the Projects and Cores within CARIB-CARES, ensuring that activities are aligned with the goals and the mission of the Center; 6) Create and ensure the continuous participation of the External Advisory Committee in the activities related to CARIB-CARES, ensuring that program goals and deliverables are monitored and met. To attain the proposed aims, CARIB-CARES will collaborate with relevant academic and research institutions, research programs, and community organizations from PR, the USVI, and the continental US. The AC will ensure the successful creation, implementation, and sustainability of CARIB-CARES as a novel research center that will help mitigate the negative impacts of natural and environmental hazards on the cancer care continuum in PR and USVI and will look for opportunities to improve the health of these US Caribbean communities, and potentially use lessons learned in other US states in the future.

Public health relevance
The US Caribbean is vulnerable to natural and environmental hazards and their impact on the cancer control continuum. The Caribbean Cancer Research Center on Environmental and Natural Hazards (CARIB-CARES) will increase capacity at PR and USVI to develop, support, and sustain research, preparedness, and adaptation capacities to help mitigate the impact of natural disasters and environmental pollution on the health of the population, within the context of the cancer prevention and control continuum.